Genomics Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Genomics Core is to provide instrumentation, computational infrastructure, technical and
analytic expertise, and guidance in order to broadly enable and to enhance the use of genomic analysis in Cystic
Fibrosis (CF) research. Among other areas of research focus, the Genomics Core places a special emphasis in
understanding host-microbe interactions in individuals with CF. The Aims of the Core are to: 1) Provide
sequencing and computational resources to study microbial communities in the CF gut, 2) Provide
cutting-edge sequencing and computational resources that advance research on pathogens associated
with CF disease states, 3) Provide advanced services to understand gene expression and molecular
physiology of human cells that are relevant to CF disease states, and 4) Develop novel technologies for
the genome-scale analysis of CF microbiology.
These aims will be fulfilled by providing UW CF researchers with consultative, production, and analytical
services relevant to the following domains:
i. Consultation on genomic methods and experimental design.
ii. Data Analysis, Data Management, and Data Sharing Services.
iii. Bacterial whole genome sequencing.
iv. Metagenomic and 16S rRNA Microbiome data generation and Analysis.
v. Transcriptome sequencing (RNA-Seq) and targeted gene expression analysis (qRT-PCR).
vi. Gut microbe quantitation by Digital Droplet PCR (dPCR).
vii. New sequencing technology innovation.
In addition to defining the microbiome of the gut at various timepoints and in various disease states of
individuals with CF, the Core will play a primary role in driving projects to define how the microbiomes of the
gastrointestinal (GI) and respiratory tracts change across the full lifespan of patients with CF, and to understand
how the administration of highly effective CFTR modulators changes the composition and metabolic functions of
the microbiome and its interface with host cells.